CTSN

PROJECT SUMMARY/ABSTRACT
We propose to assemble a multi-PI/PD Linked Clinical Research Center (LCRC) at the University of Southern
California (USC) and Saint Luke’s Mid America Heart Institute (MAHI) in Kansas City – high volume centers
committed to enrolling patients in clinical trials. The USC-MAHI LCRC will leverage CTSI programs at both USC
and MAHI, while also bringing in implementation science experts from Washington University in St. Louis, and
the University of California San Francisco (UCSF) to build an educational platform that spans our centers and
trains the next generation of clinical researchers in cardiothoracic surgery. This unique LCRC will increase the
capacity of the CTSN to successfully conduct trials in regions with high disease burden, low socioeconomic
status, ethnic and racial diversity. The specific aims of the USC-MAHI LCRC are to (1) leverage USC’s
experience within the CTSN and its synergistic relationship with MAHI to increase the CTSN’s capacity to
successfully conduct clinical trials in areas of high disease burden, low socioeconomic status, and ethnic and
racial diversity, (2) foster the development of the affiliate site in the performance of randomized control trials, trial
mechanics, and increase the affiliate’s ability to independently participate in federally sponsored trials in areas
of need and high disease burden, (3) assemble a collaborative team of expert researchers at USC, MAHI, and
the NHLBI K-12 T4 Implementation Science research programs that will apply innovative implementation science
research methodology designed for sustainably improving the population-level translation of future CTSN
studies, and (4) establish a development platform that is inclusive with respect to gender and race for the next
generation of independent cardiothoracic implementation science researchers at both the primary and affiliate
sites. These specific aims will require building a large multidisciplinary team spanning multiple institutions. Aim
1 will be conducted through the robust multidisciplinary clinical networks at both the primary and affiliate site,
while Aim 2 will involve an innovative and novel mentoring plan between the primary and affiliate site, which
leverages multiple entities, including the Clinical and Translational Science Institutes at both sites. Aim 3 will be
accomplished by bringing experts in implementation science at USC, MAHI, Washington University in St. Louis,
and the University of California San Francisco into the CTSN infrastructure to assist with trial design and
execution. Healthcare policy and economic experts at MAHI and the Schaeffer Center for Health Policy &
Economics at USC will also engage the CTSN. Aim 4 will be addressed through the formation of a Clinical and
Implementation Research Skills Program Plan which, while based at USC, will leverage resources across
multiple institutions including the clinical trial, community engagement, and KL2 programs at the Southern
California and Frontiers Clinical and Translational Science Institutes, the Mid America Heart Institute
Cardiovascular Outcomes Research Fellowship (T32 program), and our experts in implementation science.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bowdish, Michael Eugene PROJECT NARRATIVE We propose to establish the University of Southern California Cardiovascular and Thoracic Surgery Stimulating Access to Research in Residency (USC-CVTS StARR) Program to foster the development of clinician- investigators in the field of cardiovascular and thoracic diseases, by enhancing the recruitment and retention of talented residents into successful research careers, while also meeting requirements for medical board eligibility. Three highly competitive training programs in the Department of Surgery, the General Surgery Residency Program, the Integrated Vascular Surgery Residency Program, and the Integrated Cardiothoracic Surgery Residency Program, are uniquely positioned to participate in the R38 program. Through the development of an Independent Career Development Plan (ICDP), composed of research, education, and mentorship components, we will establish a program that will lead to both clinical and research competency and establish a lifelong methodological foundation overlaid with additional competencies in communications, grant-writing, leadership and team science that are requisite for success as independent career investigators. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page